Administrative Core

SPECIFIC AIMS: ABSTRACT
The Florida-California Cancer Research, Education & Engagement (CaRE2) Health Equity is proposed by
the University of Florida (UF), Florida A&M University (FAMU) and University of Southern California (USC) to
eliminate cancer health disparities in Florida, California and nationally. The Center builds on the strong
foundation of the Florida Minority Cancer Research & Training (MiCaRT) Center, an NIH/National Cancer
Institute P20 Center, which supported the infrastructure development and planning for the triad partnership. The
Administrative Core of the CaRE2 Center will serve as the hub of the CaRE2 Center's activities, including the
management, coordination, supervision and promotion of the Center's activities. The administrative leadership
will be primarily responsible for the Center's strategic planning, including: defining and upholding its mission and
objectives, conducting environmental scanning for strategy development, directing and managing strategy
implementation, and ensuring adjustments are made for continuous quality improvement (CQI) based on
program evaluation. The established benchmarks for the success of the Administrative Core are: (1) Integrated
research efforts focused on cancer disparities research by a minimum of six UF-FAMU-USC collaborative
teams. Three (3) research projects are submitted as part of this application and we anticipate making three
additional awards between Years 2 and 4 (with additional extramural projects anticipated); (2) Integrated
research education efforts focused on increasing the pool of underrepresented minorities focused on cancer
research; (3) Integrated community outreach efforts focused on engaging minority populations to collaborate
on cancer research that reflects mutual interests; (4) Successful dissemination efforts that address cancer
disparities in sub-populations of Blacks and Latinos via the Center's websites, publications, webinars,
conference presentations, community outreach events, and educational activities; and (5) Submission of NIH
K-series, T-series, and R-series grants led or co-led by a FAMU investigator.